Extension and Dissemination Core

Extension and Dissemination Core Summary
The Extension and Dissemination Core (Extension Core) will facilitate the dissemination and expansion of
all components of the Mobile Toolbox Research Platform, including the assessment library, technology
infrastructure, and the data contained in the central data repository. The Extension Core will also provide
guidance and support to researchers regarding how to 1) add measures to the MTB library; 2) select and use
MTB measures for study-specific aims; (3) perform app creation, study management, data collection, and data
repository functions; and 4) share appropriately consented and de-identified data for public use. In addition to
supporting teams that require a complete end-to-end solution, the Extension core will also support research
teams that wish to extract tests for independent use and integrate independent apps with the MTB services. We
will enlarge our support services to include additional documentation, training, and tutorials, enabling researchers
to access and use new MTB measures and data types, as well as create an MTB Help Desk providing same-
day responses to inquiries. The Extension Core will promote the MTB in presentations and exhibits at
professional conferences and meetings, manuscript submissions, and through linkages to relevant government,
non-profit, professional and consumer organizations. We will vigorously promote awareness of the MTB via
multiple modalities, including social media, so that potential users can learn how the MTB can benefit their own
research activities. We will facilitate the utilization and continued growth of the MTB system by establishing a
framework for sustainability and providing guidelines for data-driven test selection, guidelines and templates for
data sharing and new measure development, and consultation and support for users. Our Aims for MTB2 are:
Aim 1: Extend the assessment library and research platform by implementing new non-cognitive and
cognitive measures and supporting external research teams in the development of custom extensions
and configurations. To ensure that the MTB library represents the most relevant, up-to-date assessments we
will continue to open the library for extension and improvement by external developers and investigators. The
library will accommodate and implement extensions from across the research community, including measures
approved by the Steering Committee (SC).
Aim 2: Promote increased use of the MTB and MTB data by clinical researchers, mobile data
analysts, and external developers. We will expand both outreach and support services to maximize the
broad and extensive use of the MTB and its data across a diverse research community. The Extension
Core will take a multipronged approach to accomplish this aim by 1) supporting external researchers in the
selection and use of mobile measures; 2) supporting public use and re-use of MTB data; and 3) establishing
a framework for long-term sustainability and continued evolution of the MTB.